Social Reward Processing Across the Lifespan: Identifying Risk Factors for Financial Exploitation Diversity Supplement

Project Summary
Older adults are often victims of financial exploitation, which results in annual losses of at least $3 billion. Threat
of exploitation may be greater in those at risk for Alzheimer’s Disease and Related Dementias (ADRD). While
most cases of financial exploitation are perpetrated by strangers, perpetration by individuals within the victim’s
social network (e.g., friends and family) is common. Although these observations highlight the social nature of
financial exploitation, we know very little about how neural systems in older adults and those at risk for ADRD
integrate information from the social domain to inform financial decision making. Tasks involving social
information processing evoke activation in the temporal-parietal junction (TPJ) and dorsomedial prefrontal cortex;
whereas tasks involving financial decision making and reward processing evoke activation in the striatum and
ventromedial prefrontal cortex. It remains unclear whether responses within these neural systems—and
connectivity between them and other regions—differ as a function of age and risk for financial exploitation. We
recently demonstrated age differences in TPJ response during social decision-making in the context of financial
exchange (e.g., trust and fairness). We have also shown that the influence of social context (e.g., presence of a
peer) on striatal responses to reward is attenuated in older adults relative to younger adults. Building on these
exciting preliminary data, the goal of the current proposal is to characterize neural responses during social
decision making and reward processing across adulthood and quantify how these responses relate to risk for
financial exploitation. We will recruit a large sample of adults (ages 21 to 80+ years) to participate in a
neuroimaging experiment investigating social reward processing and the interplay between social context and
financial decision making. We will also administer neuropsychological and health assessments, as well as
questionnaires assessing socioemotional functioning and risk for financial exploitation. Our project will address
three aims. We will examine how neural responses to social and nonsocial reward and decisions based on trust
and fairness differ across the lifespan (Aim 1). Although neural responses evoked by our tasks may be
associated with risk for financial exploitation, it is imperative to determine how such responses interact with
sociodemographic factors, cognitive decline, socioemotional functioning, and health (Aim 2). Notably, our
quantification of health status will leverage two understudied risk factors for ADRD—vascular health and white
matter hyperintensities—and relate these factors to financial exploitation. Finally, we will re-test a subset of
participants with mild cognitive impairment (MCI) two years after their baseline visit and assess changes in social
reward processing and risk for financial exploitation (Aim 3). Overall, our project will generate new insights into
the interplay between social and financial decision making across the lifespan and individuals at risk for ADRD
and start the road to translation by characterizing risk factors for financial exploitation among vulnerable groups.

Public health relevance
Project Narrative Risk for financial exploitation has both been associated with diminished cognitive abilities (e.g., reduced executive functioning), Alzheimer’s Disease, depressive symptoms, and a range of demographic variables (e.g., socioeconomic status, sex, and ethnicity). Yet, it remains unclear whether age-related differences in neural processing of social and nonsocial rewards underlie these relationships. Understanding the role of altered reward-processing mechanisms will help establish a foundation for future work aimed at characterizing and mitigating risk for financial exploitation in older adults.